Synergistic Nanobodies for Pandemic Preparedness

Project Summary
Betacoronaviruses (beta-CoVs), including SARS-CoV-1, MERS-CoV, and SARS-CoV-2, have reshaped our
understanding of pandemic preparedness. These viruses demonstrate a remarkable ability to mutate and evade
defenses, continuing to infect populations worldwide despite extensive vaccination efforts and antiviral therapies.
The chameleon-like nature of SARS-CoV-2, particularly its modifications to the Spike protein, consistently
outpaces existing countermeasures, necessitating new strategies. This proposal introduces a pioneering class
of nanobodies (Nbs), engineered from the immune system of llamas, designed to provide comprehensive
protection against all beta-CoVs. These biologics not only advance treatment but also signify a pivotal step in
pandemic preparedness, equipping us to outpace the relentless evolution of beta-CoVs. Our innovation lies in
developing multivalent, synergistic combinations of broad-spectrum, high-efficacy Nbs. By harnessing these
combinations, we amplify their efficacy and scope, concurrently increasing their resistance to viral mutations.
Administered intranasally or directly to the lungs, these Nbs serve as both prophylactics and therapeutic agents.
Our first Aim is to strategically expand upon our proven repertoires to identify, isolate, and characterize a much
larger and more diverse repertoire of Nbs that collectively are strongly neutralizing across the beta-CoVs. We
will use cutting-edge methods to produce diverse Nbs from llamas exposed to spike proteins of various beta-
CoVs, selecting those with high affinity, specificity, and stability. We aim to discover synergistic, escape-resistant
Nb pairs through combination testing and structural analysis. In our second Aim, we will optimize critical
parameters important for developing broadly neutralizing Nb combinations and derivatives for human use. We
will evaluate the in vivo synergistic potential of Nbs targeting major threats like MERS-CoV and SARS-CoV-2,
and engineer Nbs to optimize their properties and efficacy in preparation for clinical trials. Deploying these pre-
programmed Nbs at an outbreak's onset will protect first responders and medical personnel, reduce hospital
surges, limit transmission, and buy time for new vaccine development and rollout. They will also provide crucial
support to immunocompromised individuals, safeguarding the most vulnerable from the start. We hypothesize
that our synergistic Nb combinations will introduce new beta-CoV neutralization methods, effectively prevent and
treat infections, and maintain efficacy against emerging beta-CoV threats.

Public health relevance
Project Narrative Betacoronaviruses, such as SARS-CoV-2, have shown an alarming ability to mutate and evade existing defenses, making it challenging to control their spread despite vaccination and antiviral efforts. This proposal introduces a new class of nanobodies, special monoclonal antibodies derived from llamas, with the aim of developing potent neutralizing nanobody combinations designed to provide comprehensive protection against all betacoronaviruses in support of pandemic preparedness. These nanobodies can be administered intranasally or directly to the lungs, offering immediate protection and treatment, particularly critical for first responders and immunocompromised individuals.